Determining whether TMS changes the brain through brain synaptic plasticity

Transcranial Magnetic Stimulation (TMS) has transformed the approach to neuropsychiatric illness
although many limitations remain. Without a mechanistic understanding of how TMS produces lasting
therapeutic changes in the brain, advances will be serendipitous and TMS will only reach a fraction of its
potential. There are unlimited combinations of parameters possible in TMS including stimulation intensity,
frequency, pulse width, time on and off, patterns, and anatomic location. Moreover, the way each of these
parameters affect the brain will change based on brain location, regional cell types, circuits and activity
patterns specific to each disorder, and brain state will all determine outcome. It is therefore essential to
establish the basic mechanism of TMS effects, so that the explosion of clinically-orientated,
hypothesis-driven research will have a mechanistic rationale.
Building on the extensive animal work in synaptic plasticity, I will bridge the basic neurobiological
mechanisms of learning and cognition learned in my dissertation with the translational work of TMS I have
learned during residency to address the major gap in TMS research: how does it produce lasting
therapeutic changes in the brain? A mechanistic approach to this question remains essentially untested. I
hypothesize that excitatory TMS (including high-frequency repetitive (r)TMS and intermittent theta-burst
stimulation (TBS)) induces long-term potentiation (LTP), and inhibitory TMS (including low-frequency
rTMS and continuous TBS) induces long-term depression (LTD). Both of these processes depend on
neuronal and NMDA receptor activity, and both are under the influence of inhibitory gamma-aminobutryric
acid (GABA) innervation.
I propose a series of experiments in healthy human subjects combining pharmacologic manipulation of
the LTP and LTD cascades with TMS treatment protocols to the motor cortex. Electrophysiologic
approaches assessing motor evoked potentials (MEPs) with electromyography (EMG) will allow further
elucidation of the contribution of glutamatergic versus GABAergic inputs, and will directly impact
stimulation strategies. A mechanistic understanding of TMS-induced changes to the brain could unleash
its full therapeutic potential, and thereby, transform the treatment of brain disorders.